Equipment Supplement for 7R15GM150043-02: The role of master regulator NtrC in amyloid fibril dependent pathogenic traits of Pseudomonas aeruginosa

Project Summary/Abstract
Pseudomonas aeruginosa is a versatile pathogen, capable of infecting numerous human tissues and inflicting
irreversible, life-threatening damage. Not only can P. aeruginosa survive on the nutrients released from the
damaged host cells and/or tissues, but importantly, this bacterium has the propensity to adapt and protect itself
from any defensive measures taken against it whether from the immune response of the host organism or
external remedies such as antibiotic treatments. It is the long-term goal of the proposed project to neutralize or
counter these key aspects of P. aeruginosa pathogenesis through the specific targeted disruption of the
enhancer-binding protein (EBP)-RpoN regulatory network. RpoN and EBPs interact with each other to activate
transcription of >200 target genes in P. aeruginosa. Many of the EBP-RpoN targeted genes are essential for the
utilization of host-derived nutrients and provide resistance against cell-damaging agents, including peroxides,
heat and antibiotics. The central hypothesis of the proposal is that the EBP NtrC regulates the expression of
amyloid fibrils − as well as additional proteins − that allow for P. aeruginosa to bind to eukaryotic cells and gain
a foothold in the host environment. The rationale for the proposed study is that knowledge of both the gene-
regulatory networks and pathogenic roles for NtrC will provide crucial insight into the molecular mechanisms and
signals that coordinate the adaptation of P. aeruginosa to a eukaryotic-host environment. In Specific Aim 1, the
regulon of NtrC will be defined. The chromosomal DNA-binding sites for NtrC will be determined via chromatin
immunoprecipitation with exonuclease treatment-high-throughput sequencing (ChIP-exo). Additionally, the
transcriptome of NtrC will be identified using RNA-seq. The results of the ChIP-exo and RNA-seq together will
identify the gene-regulatory network directly governed by NtrC. In Specific Aim 2, the roles of amyloid fibrils and
its regulator NtrC will be investigated in terms of adhesion and cytotoxicity towards eukaryotic cells. The
approach is innovative because it will establish whether amyloid fibrils and its regulator NtrC are required for cell
adhesion of P. aeruginosa in a host environment. It will also serve as a template for using ChIP-exo in the
characterization of EBPs or DNA-binding proteins in other pathogenic microorganisms. We are getting closer to
having a complete definition of EBP-RpoN regulation in this important human pathogen. The proposed project
is significant, because knowledge of this regulation and the resistance mechanisms it controls will facilitate the
development of antimicrobials and alternative approaches to counter the virulence or pathogenesis of P.
aeruginosa.

Public health relevance
Project Narrative The proposed project is relevant to public health because understanding gene regulation that contributes to the invasiveness and pathogenesis of Pseudomonas aeruginosa will provide alternative approaches to combat this pathogen. Therefore, the proposed project is relevant to the part of NIH's mission that pertains to developing fundamental knowledge about the nature and behavior of living systems in order to enhance health, lengthen life, and reduce the burdens of illness.